TIME STRUCT DETERMINATION OF PHOTOACTIVE YELLOW PROTEIN INTERMEDIATES

Diffraction data were collected from various intermediates formed in the light cycle of the photoreceptor, photoactive yellow protein (PYP). These intermediates were trapped at various temperatures (170 - 70 K). At 70 K, an intermediate displaying isomerization of its chromophore is predominate in the crystal.